PROTEIN STRUCTURES

Use of monochromatic data collection to investigate protein structures including human histamine IV-methyl transferase, chloroplast malate dehydrogenase, Tyr R, and insulin receptor.